Involvement of Noncanonical Short RNAs in gene repression through the RNA-induced-silencing complex

ABSTRACT
MicroRNAs have been studied for over two decades and found to impact extensively on various
cellular functions like differentiation, proliferation and oncogenesis through regulation of gene
expression using the Argonaute (Ago) containing RNA-induced silencing complex (RISC). In
the cell, however, microRNAs co-exist with a nearly equal abundance of non-canonical short
RNAs (ncsRNAs) that were not believed to enter the RISC. This has begun to change with our
discovery that some members of the ncsRNAs, the tRNA derived fragments (tRFs) enter into
RISC and silence gene expression, and others do not. The 18-26 base long tRF-3a molecules
are derived from tRNAs by processes very different from the biogenesis of microRNAs, and yet
repress gene expression by incorporation into Ago-RISC (RISC). In Aim 1 we will focus on
specific tRF sub-classes, tRF-3b and tRF-1, that do not enter into Ago-RISC, to identify the
surveillance pathways that keep short RNAs from dysregulating gene expression through RISC.
We will study a methyltransferase that inactivates tRF-3b molecules by modifications on the
RNA, a modification that is also regulated by demethylases that are inactivated by Isocitrate
Dehydrogenase (IDH) mutations, seen in many cancers. We will also focus on an RNAse that
degrades tRF-1 molecules to prevent them from entering into RISC and silencing gene
expression. The results will reveal how the surveillance mechanisms work and how pathogenic
or therapeutic alteration of the surveillance mechanisms will alter gene expression and improve
RNA mediated therapy. In Aim 2 we will turn to ncsRNAs, exemplified by three tRF-3a
molecules, that enter into RISC, silence gene expression and alter phenotypes of cancers and
cancer cell-lines. We will test whether even in these cell line the tRF-3a molecules regulate
gene expression by hijacking microRNA specific mechanisms and thus alter cellular
phenotypes. We will also determine whether the ncsRNAs help or hinder microRNAs from
doing their function. The field of short RNA mediated post-transcriptional gene regulation will be
altered fundamentally by the recognition that microRNAs work in a complex milieu of other short
RNAs that compete with or assist microRNAs, and that the cell has evolved mechanisms to
protect the integrity of microRNA-mediated gene regulation.

Public health relevance
In this project we will focus on poorly studied noncanonical short RNAs, tRFs, that are generated by mechanisms very different from microRNAs and yet several of them are now known to enter into microRNA mediated gene regulatory machinery (RISC). This project will identify specific surveillance mechanisms that keep many tRFs out of RISC, mechanisms that can be altered in pathological conditions and for therapeutic purpose. In parallel, the project will study those tRFs that elude the surveillance mechanisms and enter RISC, to determine their effects on gene regulation, cellular phenotypes and microRNA mediated gene expression, thus significantly expanding our understanding of RNA mediated post-transcriptional gene regulation.